New GORDON RESEARCH CONFERENCE: Advanced Cell and Tissue Biomanufacturing: Technology Development and Innovation through Convergence

The recent interest in advanced cell and tissue biomanufacturing offers new opportunities to spur
research, education, and industry growth and innovation. Evolution of tissue engineering, regenerative
medicine, and additive manufacturing enables the generation of various therapeutic cells and tissues for
disease diagnosis, treatment, prevention, and management. Tissue models and organoids have
emerged as a way to better understand disease and streamline pharmaceutical development. Despite
this progress, the high-level of complexity of the bioproducts relative to other medical products calls for
an equivalent high-level convergence and integration—which has yet to emerge—to lead to the
production of reliable, scalable, robust, and reproducible constructed tissues on demand. Harnessing
these recent advancements, a new Gordon Research Conference entitled “Advanced Cell and
Tissue Biomanufacturing: Technology Development and Innovation through Convergence” will
identify gaps and challenges that will stimulate new science and technology innovation in advanced
biomanufacturing. The conference will highlight the intersection of academic forces with industry niches
to accelerate the translation of lab discoveries into industrial scale production of cell and tissue products.
Development of enabling technologies and new methods for material and cell sourcing, process modeling
and integration, tissue biomanufacturing automation, on- and off-line sensing and control, tissue
development and maturation, product validation and functional assays, cell and tissue preservation,
regulation, and QA/QC as well as workforce training are essential to foster growth and sustain the field.
The meeting will offer a platform for productive interactions across the spectrum or science and
engineering from junior investigators and students to leaders in the field. Such interactions will help them
to explore new directions of research and build their careers in advanced biomanufacturing. Special
attention will be paid to enhancing diversity among investigators and understanding the cultural impacts
of these novel interventions.

Public health relevance
The promise of regenerative medicine is the replacement of damaged or diseased cells, tissues and organs, but the field is stymied by the challenges in moving beyond bench-top proof-of-principle demonstrations to robust and reliable products. Manufacturing and Regulatory complexities have been identified as the main roadblocks to progress. The new Gordon Research Conference, “Advanced Cell and Tissue Biomanufacturing: Technology Development and Innovation through Convergence” will address issues surrounding this transition to industrial standards and scale, and accelerate the establishment this next generation of health care.